Innovative Multiscale Modeling Techniques for Membrane-Bound Proteins

Innovative Multiscale Modeling Techniques for Membrane-Bound Proteins
SUMMARY
Our laboratory develops computer models to investigate biomolecular diffusion and interactions with a
particular emphasis on membrane-bound proteins and lipid metabolism. The study of diffusion using empirical
techniques faces serious obstacles in capturing the intermediate-state details of kinetic processes. Even
computational tools encounter inherent tradeoffs in balancing long-timescale simulations with those that reveal
precise atomistic details, particularly for lipid droplet (LD) proteins. This R35 MIRA proposal has two
complementary research directions. First. we will develop computational tools to model diffusion and
molecular interactions and apply them to the SARS-CoV-2 spike protein, otherwise well studied during
pandemic-related research and similar to other viruses. My research offers to accelerate drug discovery,
coronavirus vaccine development, and treatments for other viruses. Second, we will investigate the protein
networks that regulate lipid metabolism on LDs, focusing on how the ABHD5 protein interacts with LD
membranes and lipid-regulating proteins. By combining computational approaches and experimental
validation, my long-term research trajectory aims to advance understanding of lipid metabolism and inform
potential therapeutic strategies for diseases that include diabetes and cancer.

Public health relevance
NARRATIVE Our research is dedicated to pioneering computational methodologies for the study of biomolecular diffusion and interacitons. By probing into the influence of glycosylation on ligand diffusion of the spike protein, we will deepen our understanding of glycan-mediated processes, facilitate the development of glycan-targeted therapies, and gain insights that can be applied across various viral systems. We will also investigate the molecular mechanisms of protein functions on lipid droplets to enhance our understanding of lipid metabolism and establish a foundation for new therapies targeting diabetes and treatment-resistant cancers.